A Novel Cognitive Training Intervention for Depression

DESCRIPTION (provided by applicant): The long-term objective of this Patient-Oriented Mentored Career Development Award (K23) is to support the development of the candidate in translational cognitive neuroscience and clinical trials for mood and anxiety disorders. This will be accomplished through a structured supervised research experience and formal instruction that will focus on the training areas of (1) Clinical Research Methodology, Treatment Development, Biostatistics and Ethics; and (2) Cognitive and Affective Neuroscience. The specific objective of the proposed research is to conduct a proof-of-concept study investigating the efficacy of a novel cognitive training paradigm on improving depression, cognitive and affective processing biases, and neurocognition. The proposed research translates a well established cognitive bias in major depressive disorder (MDD), working memory bias, into a novel intervention target. In a double-blind, randomized, controlled study, MDD participants will undergo 6 weeks of cognitive training sessions, with three sessions per week, There is an urgent public health need to develop more effective and well tolerated treatments for patients with major depressive disorder (MDD); cognitive training interventions aiming to modify cognitive and affective processing abnormalities underlying MDD represent a promising new strategy. The skills and data acquired and research methods developed during the K23 award period will provide the candidate with the tools required to achieve the long-term goal of becoming an independent investigator in translational cognitive neuroscience research in mood and anxiety disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: There is an urgent public health need for more effective treatments for major depressive disorder (MDD), a disabling condition associated with significant morbidity, mortality and public health costs. A large proportion of MDD patients either fail to achieve an adequate therapeutic response to currently available treatments or cannot tolerate pharmacological interventions. The proposed study aims to evaluate the antidepressant effectiveness of a novel cognitive training intervention strategy and to characterize the cognitive and affective- processing effects of this training, in an effort to develop new, effective and well tolerated treatments for MDD. __SpecificAimsTextDelimiter__ 10. Specific Aims: There is an urgent public health need to develop more effective treatments for patients with major depressive disorder (MDD). However, the cognitive and affective mechanisms of disease and treatment response in MDD remain ill defined. To address this gap in understanding, the goal of the proposed research is to evaluate the antidepressant effectiveness of a novel cognitive training intervention that specifically targets an established cognitive bias in MDD, as well as effects on measures of cognitive and affective processing biases. MDD is characterized by altered cognitive processing with a bias towards negative information compared to positive or neutral information. Preliminary cognitive training interventions have recently been developed to target this, with medium effect sizes reported for cognitive bias modification (CBM) procedures in reducing cognitive biases but only small effects in reducing depression symptoms. CBMs evaluated for MDD have primarily involved training higher-order, conscious cognitive processes (e.g. interpretation bias modification). Very effective CBMs for anxiety disorders, on the other hand, have targeted automatic or immediate cognitive processes that are directly related to the underlying psychopathology (e.g., attention bias modification). Therefore, cognitive training interventions targeted to automatic and/or preconscious cognitive processing abnormalities in MDD are warranted as potentially more effective treatment strategies. A negative affective bias in working memory is well established in MDD. Working memory is particularly impaired for emotional information in MDD and this is associated with the extent of rumination experienced and the severity of depression symptoms. Working memory and rumination both rely on prefrontal cortical structures, particularly the dorsolateral prefrontal cortex (DLPFC) and medial PFC (MPFC), which neuroimaging studies have demonstrated to be hypoactive in MDD while limbic structures such as the amygdala are hyperactive. Given the demonstrated associations between working memory and rumination at the behavioral and neural circuitry levels, and their associations with MDD symptoms, we propose to target the working memory bias in MDD with an implicit cognitive training intervention employing emotionally-relevant stimuli (Emotional Faces Memory Task; EFMT). Neuroimaging in a single non-training session with healthy individuals has shown this task to simultaneously activate DLPFC and the amygdala, but the task has not been developed or tested as a cognitive training regimen for MDD. My long-term goal is to identify cognitive processing abnormalities in mood and anxiety disorders and their neurobiological bases, and to use this knowledge to develop new treatments. Based on promising pilot data, the objective of this application is to conduct a proof-of-concept study investigating the antidepressant effectiveness of EFMT training compared to a control cognitive training (CT) that employs the same paradigm with neutral (non-emotional) stimuli, and evaluate the effects of EFMT training on biases in information- processing and neurocognition as possible mechanisms of antidepressant effect. Specific Aims: Evaluate the effects of EFMT training compared to CT on MDD symptoms, negative affective biases and neurocognition. Aim 1: Measure the effectiveness of EFMT in reducing depressive symptoms in MDD participants compared to CT. Hypothesis 1: MDD participants undergoing 6 weeks of EFMT training will demonstrate greater improvement of depressive symptoms than MDD participants undergoing the CT. Aim 2: Measure the effects of EFMT on negative affective biases in information-processing. Hypothesis 2: EFMT training, compared to CT, will result in reduced negative affective bias in information processing. Aim 3: Measure the neurocognitive effects of EMFT training. Hypothesis 3: Both EFMT and CT training groups will show improvement across neurocognitive domains. This project represents a potential paradigm shift in the way MDD is treated. The proposed intervention aims to modify a cognitive bias that is well established in MDD by implicitly training cognitive processing and underlying neural circuitry. Data collected through this study will advance understanding of cognitive processing abnormalities in MDD and the effectiveness of implicit cognitive training interventions for MDD. In terms of my career development, the proposed project will facilitate the acquisition of new research skills in the areas of clinical trials design and implementation, treatment development, and the use of mechanistic, non- symptom outcome measures focusing on cognitive and affective processing.